Center for Evaluation and Implementation Resources

Justification (include hypothesis): The Foundations for Evidence-Based Policymaking Act of 2018
mandated implementation of federal evidence-building activities. Since enactment, there has been a growing
demand for training in best practices and guide materials to conduct evaluations of VA programs consistent
with VA Evidence Act requirements. The Center for Evaluation and Implementation Resources (CEIR) will
focus on the use of program evaluation best practices in everyday VA care settings, positioning CEIR to serve
as the QUERI Evaluation Coordinating Center in support of VA field-based needs related to the Evidence Act.
Gaps Addressed (Knowledge and Practices): CEIR will develop VA training opportunities in program
evaluation skills and best practices to facilitate the development of internal operational program evaluation
capacity, promote and coordinate rapid evaluation mechanisms, provide consultation on project methods and
key resources, and collaborate with PEPReC to meet the needs of VHA leaders and workgroups.
Innovativeness: CEIR promotes innovation by consolidating services to expand VA capacities related to
program evaluation and implementation science. By coordinating services related to these areas within one
center, program evaluation and practice dissemination can be standardized, assessed, and coordinated and
opportunities for improvement more easily identified. Through these efforts, VA will develop more rapid,
flexible evaluation capacity and broader staff competency in rapid program evaluations and rapid
implementation of new programs into standard clinical care. Specific Aims: Aim 1) Expand VA’s capacity to
conduct rapid program evaluations designed to address areas of operational priority by coordinating the
application, review, selection, and reporting processes for rapid evaluation mechanisms (i.e., QUERI Rapid
Response Teams, HSRD Researchers and Evaluators in Residence); Aim 2) Develop trainings which allow for
the development VA competence in program evaluation and implementation science best practices; Aim 3)
Provide consultation on national strategic decisions intended to support activities consistent with Evidence Act
goals; Aim 4) Effectively coordinate with QUERI leadership and PEPReC to support the time-sensitive
evaluation needs of VA and VHA leaders and workgroups. Project Methods: CEIR's activities will be informed
by best-practice resources such as the QUERI Implementation Roadmap, the QUERI Program Evaluation
Guide, and legislation such as the Evidence Act. For Aim 1, an Operations Core lead will oversee the
management of ORD rapid evaluation mechanisms (i.e., submissions, review and selection, allocation of
awards, and reporting) and the creation of REDCap databases for submission tracking. A Learning Core lead
will manage the development of evaluation and implementation science trainings and resources for Aim 2 such
as TMS trainings, slide decks, evaluation and implementation guides, and community of practice calls to
support skill development. Aim 3 will be accomplished by a team lead by a Partnership Core lead with
experience in VHA operations, evaluation, and clinical research and will include targeted assessment and
outreach efforts to ensure that consultation services are available to all interested VA personnel. Aim 4 will be
supported by work efforts that span the CEIR cores and are facilitated by regular workgroup meetings with
QUERI and PEPReC leadership. Description of Primary Outcomes/Endpoints: CEIR's impacts will be
demonstrated through the growth and expansion of the number of projects supported via ORD rapid evaluation
mechanisms; through the growth of program evaluation learning communities and expanded learning
opportunities for skill development (e.g., Program Evaluation Boot Camp, "Implementation 101" slide set,
Qualitative Methods Learning Collaborative); through the development and adoption of standardized
approaches to structure, carry out, and apply the results of evaluations within VA; and through the
development and consolidation of best-practice resources related to program evaluation and implementation.

Public health relevance
VA has a strong commitment to transitioning into a Learning Healthcare System characterized by the alignment of science with clinical priorities, the development of rapid and efficient studies, and the leveraging of existing data to deploy and evaluate innovations and best practices. The Center for Evaluation and Implementation Resources (CEIR) will help with this transition by providing administrative support for rapid evaluations based on operational priorities, the coordination of training opportunities in program evaluation and implementation science best practices, and the provision of consultations on project methods, partnerships, and funding. The combination of these services will support the development of core skills among VA employees in evaluation and practice implementation and support the adoption of evidence-informed program management consistent with Evidence Act expectations.